Understanding the Molecular Rules of a Bacterial Multidrug Efflux Transporter

PROJECT SUMMARY/ABSTRACT
Antimicrobial resistance (AMR) is an accelerating pandemic contributing to a huge healthcare burden and
hundreds of thousands of deaths annually. A major player in this phenomenon is expression of multidrug efflux
pumps. These membrane transporters have the remarkable ability to export structurally and chemically diverse
antibiotics while remaining selective for toxins. Despite high clinical relevance, our understanding of polyspecific
drug efflux is limited. This is due to the complexity of overall promiscuous transport, which relies on a combination
of flexible ligand binding and proton-gated conformational change to move the substrate across the membrane.
While many mutational studies evaluating specificity thus far have focused on the binding site, I hypothesize
that polyspecificity arises as a combination of these distributed transporter functions, and as such the
determinants of substrate range are diffuse. Here, I combine deep mutational scanning with in vivo and in
vitro validations to address two Aims. In Aim 1, I measure the function of all 7,760 possible single mutants of
NorA in the contexts of ten antibiotic substrates and ten antibiotics not normally transported by NorA, validating
select variants with clonal IC50 assays. This will expose the basis of multidrug specificity, both within the binding
site and distally. Preliminary data shows that residues driving specificity may be found far from the binding site,
including several residues thought to be involved in proton coupling. In Aim 2, I will develop a high-throughput
method to measure NorA’s energy efficiency by testing various approaches to stress the proton motive force,
which NorA relies on for energy. I hypothesize variants that are highly sensitivity to basic pH, nigericin, or
valinomycin will exhibit reduced coupling efficiency. pH-sensitivity screens highlight expected variants in early
results. I will validate this using an accepted coupling efficiency assay in which variants are reconstituted into
liposomes containing the pH-sensitive fluorophore pyranine, which is currently working in my hands with control
mutants. Completion of these Aims will mark the most exhaustive study of a drug efflux pump yet, yielding a
wealth of information on how AMR arises and how we may lessen this substantial public health burden.
The training planned during this fellowship will develop my skills in design and execution of high-throughput
screens, computational analysis of large multidimensional datasets, bacterial cell biology, and advanced
biophysical techniques. Training will take place at the University of Wisconsin–Madison under the supervision of
Dr. Srivatsan Raman, an expert in high-throughput biology, with additional training and mentorship from co-
sponsor Dr. Katherine Henzler-Wildman, a renowned transport biologist also in the UW–Madison Biochemistry
department. My graduate program, Cellular and Molecular Biology, will provide training in responsible conduct
of research and professional development activities to prepare me for an impactful career in academia.

Public health relevance
PROJECT NARRATIVE Multidrug efflux pumps are major players in clinically significant antimicrobial resistance, catalyzing active transport of structurally diverse antibiotics out of the cell. Despite extensive structural and targeted functional studies, the molecular principles governing the polyspecificity of multidrug transporters and their energy coupling mechanisms remain elusive. This proposal aims to comprehensively examine the sequence-function relationships of a S. aureus multidrug transporter, allowing a detailed understanding of its multiple functions and paving the way for development of more effective strategies to overcome antimicrobial resistance.